RFA-DP-21-001 Component A: Vermont Pregnancy Risk Assessment Monitoring System

Project Summary
The Vermont Pregnancy Risk Assessment Monitoring System is designed to
improve the health of mothers and their babies. It is a survey of new mothers
that asks questions about experiences and behaviors before, during and shortly
after pregnancy. A sample of new mothers is selected each month from the birth
file, and stratified by birthweight. The mother is first sent a letter informing her
that she will be receiving a survey. The first survey mailing is sent four days
later with a cover letter that describes the project. It also includes the informed
consent, a question and answer brochure, resource information, return envelope
and a small gift as an incentive. A reminder letter is sent two weeks later to non-
respondents. A second survey packet is mailed two weeks after the tickler letter,
and then a third survey packet after two more weeks. One week after the final
mailing, telephone calls are initiated with any mail nonrespondents. Multiple
phone calls over five weeks are made in an attempt to reach the mother and
persuade her to complete a telephone interview.

Public health relevance
The Vermont Pregnancy Risk Assessment Monitoring System is a population- based surveillance system that provides state-specific data for improving the health of mothers and their infants. The information from this program is used to identify problems, to develop policies and programs, and to evaluate the effectiveness of these activities.